Assessing the impacts of Medicaid Home and Community Based Waivers for children with Severe Emotional Disturbance

PROJECT SUMMARY
The overall goal of this K01 application is to estimate the impact of 1915(c) Home and Community-Based
Services (HCBS) Medicaid waiver programs for children with Severe Emotional Disturbance (SED) on
behavioral health care service use and expenditures for children with SED. Children with severe SED are at
significant risk for psychiatric long-term care (LTC) use due to the severity of their symptoms and inability to
access alternative community-based behavioral health care. To reduce public financial burdens and family
distress associated with use of psychiatric LTC, one in five states offer 1915(c) HCBS Medicaid waiver
policies. These policies expand the Medicaid-funded community-based service array for children who exhibit a
clinical need for institutional psychiatric care, regardless of family income levels. Though these policies are
intended to prevent psychiatric LTC use by providing alternative community-supports, achievement of these
goals is unclear. Scant existing research lacks either causal inference or generalizability, as they are cross
sectional, regional, or minimally control for clinical variation in program participants. The goal of this K01 is to
train the recipient in the statistical and methodological skills needed to study the impacts of health policy on
service utilization and expenditure outcomes for children and youth with complex behavioral health needs.
Research aims are to 1) create a comprehensive SED waiver policy dataset that codifies the structures and
provisions of these policies across states and over time, 2) identify and compare characteristics of children
enrolled in SED waiver programs and children who use psychiatric LTC among Medicaid-enrolled children with
behavioral health disorders; 2b) assess SED waiver policies and waiver program enrollment’s association with
amelioration of adverse risk factors for LTC, and 3) estimate the effects of the Texas SED Waiver and its
characteristics on Medicaid-reimbursed behavioral health service use and expenditures. The training aims of
the project are to 1) acquire knowledge, skill, and experience in public health law research methods, 2) build
knowledge on the assumptions and applicability of research designs and statistical methods for estimating
causal effects of behavioral health policy interventions using observational and administrative data, 3) apply
current and best practices for defining and measuring behavioral health service use and expenditures using
diverse sources of health claims data and 4) obtain the research, writing, and administrative expertise to
submit a successful R01 grant during the final year of the K01. Training aims will be accomplished through
formal coursework, individualized instruction, seminar and workgroup participation, mentored research, and
conference participation. Research aims will use data from state SED waiver applications merged with
Medicaid claims data from state and federal resources. This project will provide novel evidence for
policymakers nationwide regarding which children may be at risk for psychiatric institutional care, the policy or
service interventions that may reduce these risks, and what costs may be associated with these interventions.

Public health relevance
PROJECT NARRATIVE The purpose of this project is to identify the structure and provisions of Severe Emotional Disturbance (SED) 1915(c) HCBS waiver programs across the United States, the characteristics of children served in these programs and the extent to which they are at risk of psychiatric long-term care (LTC) placement, and estimate the effects of an SED waiver on behavioral health care service use and expenditures for children with SED. Because these policies aim to reduce the use of psychiatric LTC through the provision of community-based alternatives—but programs and environments vary considerably across states and over time—this study will explicitly examine variation in program structures and participants and will assess policy impacts on community-based and out-of-community service use and expenditures, while accounting for contextual variation. As this study relies on data drawn from state administrative documents and public healthcare claims, this grant also provides training in research design and statistical methods for utilizing policy and claims data to address key information needs for behavioral health policy decision-making that reduces avoidable use of psychiatric LTC.